DEVELOPMENTAL IMMUNOTHERAPEUTICS FOR ALLERGIC DISEASES AND ASTHMA

This project seeks to develop novel immunologic therapies for allergic diseases as well as the laboratory techniques required to understand their mechanism of action and rational application. We have developed a highly sensitive allergen specific T cell cytokine assay, which allows us a direct high throughput means to examine cytokine responses in clinical trials. Strategies that are being pursued include the administration of sIL-4 receptor as an anti-inflammatory/Th2 tolerogenic therapy for asthma. We are applying a similar approach to mouse vaccine models to understand how DNA vaccines generate specific immune responses.To date, we have examined the cytokine response to aeroallergens, demonstrating a uniform Th2 response in allergic asthmatics but little or no detectable response in healthy controls. Thus, the normal T cell response to aeroallergens is tolerance. This suggests that the therapeutic induction of tolerance to allergens may be an attractive strategy for the treatment of allergic asthma. A proposed phase I trial using rhIL-12 as an adjuvant in allergen immunotherapy was recently terminated for regulatory reasons. Antigen specific cytokine flow has been applied to DNA vaccination of mice, demonstrating that DNA vaccination creates a long lasting Th1 polarized immune response in both CD4-positive and CD8-positive subsets, whereas protein immunization generates a more transient response limited to CD4-positive T cells. - Asthma, allergy, T cells, tolerance, therapy, vaccine, Th2 cells, interleukin-4, blood, immunomodulation - Human Subjects